FY25 TO-B

Base - Upgrade Wireless Access Points (WAP) system in Buildings 325, 433, 457, 538, 542, 555, 1011, 1028, 1031, and 1043.
Option 1 - Upgrade Wireless Access Points (WAP) system at the ATRF.